Label-free, single-molecule biosensing at ultrahigh speeds with metasurface-enhanced coherent Raman scattering

Project Summary
Surface-enhanced Raman scattering (SERS) is a popular approach for molecular biosensing, and for
a good reason: it enables the identification of molecular targets in a label-free fashion, down to the level
of single molecules. This tremendously attractive capability has triggered developments that aim to use
SERS for rapid screening of sequences of molecular residues, which would enable applications such
as sequencing the nucleobases in DNA. SERS-based sequencing overcomes persistent problems with
label-based sequencing methods, including the ability to read out longer sequences and the possibility
of directly detecting epigenetic modifications to the nucleobases. Despite successful examples of
Raman-based sensing of single molecules, the photophysics of single-molecule SERS measurements
on plasmonic substrates limits spectral acquisition rates to the 0.1-10 Hz range, many order of
magnitude below the rates needed to render SERS practical for DNA analysis and other biosensing
applications where detection speed is of the essence.
In this proposal, we overcome the fundamental speed limit in surface-enhanced Raman-based
biosensing in particular and label-free single-molecule sensing in general. We achieve label-free
detection of single molecules at acquisition rates that are at least 104 faster compared to SERS
measurements. Such unprecedented detection speeds are obtained by combining surface-enhanced
coherent anti-Stokes Raman scattering (SE-CARS) with the state-of-the-art design of dielectric
enhancement structures. Through systematic tailoring of dielectric nano-antennas, and arranging them
in a lattice, this project delivers a thermally robust enhancement platform that enables label-free single
molecule detection with microsecond signal acquisition times.
Our team is comprised of experts in coherent Raman scattering microscopy and advanced engineering
of nanophotonic metasurfaces. The proposed work is innovative in that it uniquely fuses the accelerated
signal rates of coherent Raman scattering with the latest insights in dielectric nano-antenna design. By
pushing the limits of both Raman photophysics and the collective resonances afforded by
metasurfaces, our innovation tackles a major obstacle in label-free biosensing and opens up new high-
speed applications that have hitherto remained out of reach.

Public health relevance
Project Narrative In this program, we dramatically accelerate the acquisition speed of Raman-based biosensing by more than four orders of magnitude. This new capability is achieved by accelerating the radiative rate of the Raman process through the combination of coherent Raman scattering with the enhancement properties of metasurfaces composed of dielectric nano-antennas. The unprecedented detection speed of this novel biosensing platform sets a new standard for identifying single molecules in solution, bringing label-free sequencing applications at unprecedented acquisition rates within reach.